Developing small molecule inhibitors for modulating cytokine IL18 activities

Interleukin 18 (IL18), a member of interleukin-1 superfamily, is a critical effector molecule of inflammasome
activation. IL18 signaling is initiated by its binding to the IL18 receptor (IL18R) a subunit, followed by the
recruitment of the receptor b subunit to form a ternary complex. A naturally occurring antagonist of IL18, IL18
binding protein (IL18BP), prevents IL18 from binding to IL18R, potently inhibiting IL18 activity through a
negative feedback mechanism. IL18 activities are important for immune responses to infection and tumors, but
they are also involved in some inflammatory diseases. Thus, both up- and down-modulating IL-18 activities are
pursued as therapeutic approaches for treating cancers or inflammatory diseases, respectively. The
therapeutic potential of IL18 blockage for the treatment of adult-onset Still’s disease and auto-inflammatory
hemophagocytic syndrome has been demonstrated by initial results from clinical trials with human IL18BP. On
the other hand, IL18BP was recently found to be a major immunotherapeutic barrier for anti-tumor activity of
IL18, and an engineered IL18 mutant capable of evading IL18BP inhibition showed greatly enhanced anti-
tumor effects in mouse models1. The current therapeutic approaches that involve the modulation of IL18
activities are all protein-based. The ultimate goal of our proposal is to develop small molecules that can either
up- or down-modulate IL18 activities, which can be used in cancer immunotherapy and for treating
inflammatory diseases, respectively. We have made significant contributions towards structure-function of IL18
and IL18BP2,3. We revealed three pockets on IL18 surface that interact with IL18BPs and identified small
molecules that either inhibit IL-18 activities or inhibit IL18BP binding with no deleterious effect on IL18
activities. We propose following structure-function studies of the small-molecule IL-18 modulators, which are
essential for structure-guided design of small-molecule therapeutics. Aim 1. Structure-function studies on
small molecule inhibitors of IL18. We have identified a small molecule that directly binds IL18 at a ‘hot spot’
on the surface and inhibits its bioactivities. We will carry out further mechanistic studies on the compound by
biochemical and biophysical approaches. We will carry out larger scale virtual screening, functional assays and
structural biology to identify additional compounds with different scaffolds. Aim 2. Structure-function studies
on small molecule inhibitors of IL18BP function. We have identified two compounds that directly bind IL18
at different surface locations, blocking IL18BP binding however retaining IL18 receptor signaling. We will use
similar approaches as in aim 1 to characterize these compounds and further identify additional ones as IL18BP
inhibitors. Modulating IL18 signaling with small molecules is a novel and promising approach for treatment of
inflammation and cancer immunotherapy. Successfully accomplishing the aims will not only provide a better
understanding of IL18 biology, but also provide critical platform for future development of new therapeutics
against a number of human diseases.

Public health relevance
Successfully accomplishing the aims will set up the foundation for structure based rational design of small molecules that either up or down-modulate IL-18 activities. The proposed research holds great translational potential, since small-molecule modulators of IL18 activities can be further developed into novel therapeutics for inflammatory or autoimmune diseases and cancer.